Using DNA-encoded Chemical Libraries to Develop Inhibitors of the MCR-1 Colistin Resistance Enzyme

Using DNA-encoded Chemical Libraries to Develop Inhibitors of the MCR-1 Colistin Resistance
Enzyme
The increasing prevalence of bacterial pathogens resistant to multiple antibiotics is a serious threat to global
health. The spread of multidrug-resistant Gram-negative bacterial pathogens is a particular concern. In this
regard, the increased prevalence of carbapenemase enzymes such as the KPC and NDM b-lactamases has
reduced the efficacy of b-lactam antibiotics. The limited treatment options has led to increased use of
polymyxin antibiotics such as colistin. The recent emergence and spread of a plasmid-encoded, transferable
resistance gene, mcr-1, is a cause for concern. The mcr-1 gene encodes an enzyme, MCR-1, that catalyzes
the transfer of phosphoethanolamine (PEA) from phosphatidylethanolamine to the 1’ or 4’ phosphate of lipid
A. The neutralization of the negative charge on lipid A reduces binding of the positively charged colistin,
leading to resistance. The MCR-1 enzyme contains an N-terminal membrane domain and a soluble C-terminal
catalytic domain. We have expressed and purified the full-length MCR-1 enzyme from E. coli and have shown
it is active in vitro. The availability of the purified full-length enzyme provides the basis for a biochemical screen
for small molecule inhibitors. DNA-encoded chemical libraries contain small molecules covalently attached to
encoding DNA. These libraries have proven to be an efficient means of identifying small molecules that bind
to a target protein. We screened a library containing >2 billion compounds against immobilized MCR-1 and
identified potential hits by next-generation DNA sequencing. Several putative hit compounds were synthesized
in the absence of the DNA tag and two of these molecules synergize with colistin to kill E. coli expressing the
MCR-1 enzyme. Importantly, the compounds do not alter E. coli growth rate when used alone and do not
synergize with colistin against a strain containing a catalytically inactive MCR-1 protein. We propose to validate
these chemically unique compounds by showing that they bind and inhibit the MCR-1 enzyme. In addition, we
will determine their spectrum of activity against a set of colistin-resistant clinical isolates containing the MCR-
1 enzyme as well as isolates containing the MCR-2, -3, -5, and -9 variant enzymes. Further, we will utilize
medicinal chemistry approaches to determine structure-activity relationships and identify more potent
derivatives of the compounds. Finally, we will screen new DNA-encoded chemical libraries to identify
additional novel inhibitors. The end result of these studies will be validated, potent MCR-1 inhibitors that can
be further developed with regard to pharmacological properties and efficacy in animal models in future studies.
Our goal is to identify potent inhibitors of MCR-1 that will restore the effectiveness of current and future
polymyxin antibiotics.

Public health relevance
Project Narrative We propose to further validate small molecule inhibitors of the colistin-resistance enzyme MCR-1 that were discovered using DNA-encoded chemical libraries. We will validate binding of the inhibitors to MCR-1 using biophysical methods, use medicinal chemistry approaches to determine structure-activity relationships and identify inhibitors with enhanced potency, and screen new libraries to identify additional novel inhibitors. The end result of these studies will be potent MCR-1 inhibitors that can be further developed with regard to pharmacological properties and efficacy in animal models in future studies.